Light Microscopy Core

ABSTRACT - LIGHT MICROSCOPY SHARED RESOURCE
The Light Microscopy Shared Resource (LM) provides state-of-the-art light microscopy technology for fixed
and live cells and tissues, along with scientific and technical expertise to assist in experimental design and
optimal image collection. The LM shared resource offers affordable and efficient access to over $8 million in
microscopic imaging resources, including confocal and conventional fluorescence instruments, multi-photon,
lightsheet and super-resolution to all members of the Duke Cancer Institute (DCI). Three dedicated, full-time
PhD-level staff members provide training and full technical support for all the microscopy systems. DCI members
receive special priority access to equipment, training sessions and staff assistance. Hands-on individualized
training and assistance with analysis is provided upon request to DCI members in advance of other users. LM is
supported annually with charge backs from user fees and by the DCI CCSG, the Duke University School of
Medicine and the Duke University Office of the Provost. All standard optical sectioning and fluorescence
microscopy technologies are offered including confocal, resonant scanning confocal, spinning disk, live-cell
imaging with several modalities, long-term incubated time-lapse, multi-photon, photoactivation/photoconversion
and photokinetic (FRAP, FLIP) capabilities, and in addition, new technologies – lightsheet and super-resolution.
Reservations are executed online through the university-wide software system on a first-come, first-served basis
with some limits to promote efficient use. The large range of equipment with some replication of capabilities
provides good capacity for users’ needs. LM’s continued priority is to serve the light microscopy needs of DCI
members and all Duke researchers with support and assistance on equipment and image analysis in order to
generate productivity. At the same time we keep current by demo-ing and testing new and different technologies
and strive to implement new technologies that prove valuable.
In 2018, LM provided services to 233 investigators, 40% of whom were DCI members, accounting for 55%
of total usage, from all 8 DCI Research Programs. Use of this shared resource by DCI Members contributed to
261 publications over the project period, 71 of which were in high impact journals (IF>9), demonstrating the value
of services offered by the resource.